Obesity-driven alterations in humoral B cell immunity

Obesity is a critical global epidemic, a leading cause of preventable death, and a source of skyrocketing health
care costs. To improve the health outcomes of patients suffering from the negative consequences of obesity, we
must first understand the extent of obesity-induced immunological changes. We recently connected an increase
in inflammatory Tbet+CD11c+ B cells in mice and humans to exacerbated metabolic disease (Hägglöf et al, Cell
Metabolism 2023). Tbet+CD11c+ B cells accumulate during autoimmune disease and aging, where they are
primed for activation specifically in response to innate activation via TLRs and support by T helper cells but their
specific inflammatory role during obesity is not well understood. Our preliminary data using high fat diet (HFD)
fed mice, shows that 1) Tbet+ B cells expand in spleen, liver, and adipose tissue during obesity and produce
IgG2a self-antigen-containing immune complexes; 2) T follicular and peripheral helper cells also expand in
spleen and liver during obesity; 3) Tbet+ B cells express high levels of scavenger receptor CD36, which enables
increased antigen uptake and enhanced innate signaling, while mice with a B cell restricted deficiency in CD36
develop fewer HFD-induced splenic Tbet+ B cells or T helper cells than controls; 4)eliminating Tbet in B cells
during obesity led to increased GC B and T helper cells and improved immune responses to vaccination and
infection. Thus, we hypothesize a dual signal paradigm in obesity whereby innate signaling from autoantigens
primes Tbet+ B cells for antigen/MHC-recognition and help from T helper cells. Once expanded, we posit that
Tbet+CD11c+ B cells inhibit protective GC-based vaccine responses in favor of extrafollicular expansion, which
could explain the poor clinical outcomes for vaccinated or infected obese patients.
In Aim 1, in vitro and in vivo assays, RNAseq, flow cytometry, adoptive transfer, and immunofluorescent
staining in combination with unique transgenic, TLR deficient, lineage-restricted CD36 deficient, and Tbet+ ZTCE
reporter mice all us to characterize the signals which define the innate half of the dual-signal paradigm. These
studies will also characterize metabolic changes in rare subsets using SCENITH flow cytometry. In Aim 2, we
will consider the adaptive half of the dual-signal paradigm and characterize the antigen-presenting requirements,
specificity, and nature of T cells which help Tbet+CD11c+B cells during obesity. We will utilize powerful new
lines of mice with Cre expression restricted to CD19+ CD11c+ B cells defined by expression of two proteins,
created in collaboration with Mark Shlomchik. Pairing these mice with the innovative uLIPSTIC mice will allow
us an unbiased identification and characterization of the T helper partners of Tbet+CD11c+ B cells. Finally, these
innovative mice provide exquisite tools for querying the use of IL-12 by Tbet+CD11c+ B cells to block vaccine
effectiveness in obese mice. These studies will point to a therapeutic strategy for improving quality of life and
survival in obese patients. This strategy may be applicable to immunologically related conditions such as aging
and autoimmune disease, expanding the therapeutic effect to other clinically vulnerable populations.

Public health relevance
Project Narrative Obesity is fast becoming a critical global epidemic, a leading cause of preventable death, and a source of skyrocketing health care costs. This project will identify key mechanisms utilized by a specific subset of B cells to mediate inflammation in spleen, adipose, and liver during obesity and their contribution to inhibition of humoral immune responses to vaccines during obesity. This project will be to identify new therapeutic targets which may be used to re-establish a healthy immune balance to counteract the symptoms of obesity.